Molecular Mechanisms of G protein-coupled Receptor Biased Signaling

Project Summary
G protein-coupled receptors (GPCRs) are an important superfamily of seven transmembrane proteins involved
in cell-to-cell communication essential for sensing, movement, and thought processes. A significant portion of
current approved drug therapies target GPCRs, but suffer from “on-target” side-effects related to the
engagement of differential signaling pathways known as “functional selectivity” or “biased signaling.” Exploiting
biased signaling represents a promising approach toward designing pathway-selective drugs with better “on-
target” profiles, but the mechanisms at the structural level that lead to biased signaling are still poorly
understood. Recent advances in structural details of biased ligand recognition have led to the identification of
common binding pocket motifs important for `switching' balanced agonists toward biased agonists, and vice
versa. Using a structure-based and chemical biology approach, my laboratory aims to use a variety of recently
discovered biased ligands to uncover common mechanisms within the binding pocket that govern biased
signaling at key GPCR targets. Strategies will incorporate a combination of structure-guided mutagenesis, use
of structure-activity relationships (SAR) for recently discovered biased ligands, and high-throughput assays
measuring ligand kinetics, G protein dissociation, second messenger production, β-arrestin recruitment, and
internalization. This approach focuses on molecular determinants between G protein and β-arrestin-bias
agonism at key receptors that have historically shown biased agonist phenomena. Through these studies, a
comprehensive mechanistic understanding into GPCR biased signaling will guide researchers toward
generations of superior therapeutics.
1

Public health relevance
Project Narrative G protein-coupled receptors are important drug targets that can exhibit preference for signal transduction pathways, a phenomenon known as biased signaling. To design pathway-selective drugs, mechanistic understanding at the molecular level is required to identify structural motifs that govern biased signaling. Using chemical and structural biology approaches, this project focuses on uncovering these structural motifs by employing structure-based mutagenesis, biased ligands, and in vitro assay platforms to identify common mechanisms of ligand bias at key receptor targets. 1